Characterization and function of a new p75-NTR+ cellular network in craniofacial bone

PROJECT SUMMARY
There is a critical need for new methods to accelerate and enhance skeletal regeneration. This is
generally dependent on two main factors. First, the recruitment and differentiation of suitable osteoprogenitor
cells. Second, the upregulation of key osteoanabolic pathways that coordinate cell proliferation and the
osteogenic cascade. Novel methods to enhance one or both of these factors are needed to significantly
advance the field. In 2010, it was discovered that regions of neural crest-derived bone within the craniofacial
skeleton have superior regenerative capacity; this is true in terms of both the speed of the skeletal
regeneration and the total amount of bone formed. In 2015, it was further established that these regions have
enhanced osteoanabolic signaling and increased expression of genes related to proliferation, self-renewal, and
the stem cell niche. In 2021, it was confirmed that these findings extend to humans. However, the upstream
mechanisms driving this remain as yet unknown. In addition, the ability to replicate this pro-regenerative
program at other skeletal sites has not yet been achieved. This represents a key gap in knowledge. To
overcome this, we recently identified a unique p75 neurotrophin receptor-positive (p75-NTR+) periosteal cell
population that forms a dense network specifically over the surface of the pro-regenerative region of neural
crest-derived bone. This network is persistent even in adult animals and is absent in neighboring regions and
calvarial bones of mesodermal origin. P75-NTR is a 427-amino-acid transmembrane receptor that forms
heteromeric complexes with other receptors and binds to a broad array of neurotrophins such as nerve growth
factor, which is also known to be osteoanabolic. P75-NTR has also been identified as a marker of neural-crest
derived stem cells. Our central hypothesis is that this robust p75-NTR+ cellular network represents the basis of
the superior pro-regenerative properties of neural crest-derived bone. The work in this project will begin by
characterizing this unique cell network (Aim 1). Second, we will determine if this is a transplantable progenitor
population that can be used to promote regeneration at other skeletal sites (Aim 2). Last, we will use a clinical
p75-NTR modulator as a strategy to enhance local osteoanabolic signaling and bone formation (Aim 3). When
complete, we anticipate that our results will yield valuable basic and translational information that will promote
biologically inspired tissue engineering strategies to enhance craniofacial and orthopedic bone regeneration.

Public health relevance
NARRATIVE Skeletal and craniofacial defects are functionally debilitating and contribute to social, biomedical, and economic challenges for affected patients. Current methods for regeneration can often lead to poor results, despite multiple procedures. Identification of novel cellular and molecular mechanisms to enhance and to accelerate regeneration will lead to improved outcomes.